OBESITY, BIOMECHANICS, AND INFLAMMATION IN OSTEOARTHRITIS

DESCRIPTION (provided by applicant): Osteoarthritis (OA) is a painful and debilitating disease of the synovial joints, affecting an estimated 27 million people in the United States. As the prevalence of obesity has risen dramatically in the past two decades, we now know that obesity is likely to be the primary preventable risk factor for OA. The goal of this project is to examine the influence of dietary fatty acids on obesity-associated OA in mice, and to examine their interaction with altered biomechanical and pro-inflammatory cytokines using various in vivo and in vitro models. We propose that low-grade chronic systemic inflammation - due to obesity or pro- inflammatory fatty acids in the diet - acts in synergy with local inflammatory cytokines or altered mechanical loading following injury to promote a state of inflammation and matrix degradation in the articular cartilage. We will pursue the following aims: In Aim 1, we will examine the role of a high-fat lard- based diet in the development of OA in a leptin-receptor deficient mouse (db/db), and we will also measure osteoarthritic changes in diet-induced obese mice fed high-fat diets high in saturated and monounsaturated fatty acids, or omega-3 or omega-6 poly-unsaturated fatty acids. In Aim 2, we will examine the effects of obesity (via high-fat diet or leptin deficiency) and weight loss on the progression of OA in a destabilized medial meniscus model of mouse OA. In Aim 3, we will use controlled in vitro models of cartilage explant loading to examine the effects of mechanical stress in combination with pro- inflammatory cytokines and fatty acids on the anabolic and catabolic activities of the chondrocytes, as measured by biomarker production, gene expression, and protein synthesis of collagen II and aggrecan. Detailed studies of the interactions between specific biomechanical factors, pro-inflammatory mediators, and tissue metabolism in articular cartilage will improve our understanding of the pathology of the OA, particularly as it relates in vivo to biomechanical factors such as obesity, injury, or weight loss. The results of this study will provide new insight into key elements of the pathogenesis of OA, and ultimately could lead to new treatments that exploit physical, dietary, and molecular therapies to prevent disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this project is to examine the influence of dietary fatty acids on obesity-associated osteoarthritis in mice, and to examine their interaction with altered biomechanical and pro-inflammatory cytokines using various in vivo and in vitro models. We will test the hypothesis that low-grade chronic systemic inflammation - due to obesity or pro-inflammatory fatty acids in the diet - acts in synergy with local inflammatory cytokines or altered mechanical loading (due to obesity or joint instability) to promote a state of inflammation and matrix degradation in the articular cartilage.